The preliminary efficacy of a culturally tailored, telehealth lifestyle intervention for Black adolescent girls with prediabetes: a pilot randomized controlled trial

PROJECT SUMMARY
Type 2 diabetes mellitus (T2DM), an obesity-related chronic disease, disproportionally impacts the lives of
Black adolescent girls, which contributes to racial/ethnic disparities in T2DM incidence and mortality rates
experienced by Black women. Diet and physical activity are shown to reduce T2DM risk, but Black adolescent
girls with T2DM are not meeting recommendations for either. Lifestyle interventions for adolescents primarily
target those with prediabetes (not T2DM), are adaptations of the Diabetes Prevention Program, and only
modestly reduce T2DM-risk factors. Limitation of existing T2DM-related lifestyle interventions include: 1)
barriers to program participation, 2) barriers to making and sustaining behavior changes, 3) do not include a
cooking component, 4) are not culturally tailored, and 5) evaluate changes in body mass index but not in
glycemic measures (e.g., glycated hemoglobin, oral glucose tolerance test), which is a direct predictor of
T2MD. For the proposed study, we will examine the preliminary efficacy of our 12-week culturally tailored,
telehealth lifestyle intervention called Black Girls for Wellness (BGW). The study is informed by the Social
Cognitive Theory, which posits that personal (e.g., self-efficacy), behavioral (e.g., skills), and environmental
(e.g., social and physical) factors influence behaviors (e.g., diet and physical activity) and health outcomes
(e.g., body composition and glycemic measures). Each week participants will engage in 3 activities: 1) a live
stream group nutrition lesson and check-in (60 min/week), 2) a cooking experience at home preparing a
healthy ethnic meal using ingredients sent via Amazon Fresh (60 min/week), and 3) live stream Afrocentric
dance classes (60 min 3 days/week). We will recruit Black adolescent girls (12-18 y) with overweight or obesity
and prediabetes from the New York Presbyterian-Weill Cornell Medicine Pediatric Endocrinology Clinic
(Manhattan, NY) to participate in a pilot randomized controlled trial (RCT) (n=60; 30-intervention, 30-control).
After end-point data collection, the control group will participate in the BGW. The proposed study is innovative
through the use of telehealth delivery methods, hands on cooking experiences and physical activity that are
culturally tailored, and glycemic measures that are proximal to T2DM risk. The American Diabetes Association
recommends telehealth and culturally tailored lifestyle interventions to address systems level inequities in
healthcare access, yet these methods have yet to be explored with Black adolescent girls with prediabetes.
Our central hypothesis is that the intervention group will experience significant improvements in diet quality
(primary outcome), physical activity, body composition, and glycemic measures, as compared to the control
group. The long-term goal is to establish an evidence-based, culturally tailored, telehealth diabetes prevention
intervention that can be scaled to address the needs of Black adolescent girls with prediabetes, a high risk and
underserved population.

Public health relevance
PROJECT NARRATIVE The incidence of type 2 diabetes mellitus (T2DM) is rising at an alarming rate for Black adolescent girls and there is a critical need for lifestyle interventions that target T2DM-related risk factors (e.g., diet and physical activity) among this high risk and underserved population. We will conduct a pilot randomized controlled trial of our 12-week theory-informed culturally tailored, telehealth lifestyle intervention called Black Girls for Wellness (BGW), which consists of livestream group nutrition lessons, home cooking experiences (healthy ethnic meals) using ingredients sent via a grocery delivery service, and livestream Afrocentric dance classes. Our overall aim is to, 1) improve diet quality (primary outcome), physical activity, body composition, and glycemic measures, and 2) develop a T2DM prevention intervention curriculum that is feasible and acceptable.